Methods Core

The Methods Core supports a Signature Project, 3 Exploratory Projects, and 4-6 Pilot Feasibility Projects
focused on health-justice big data linkage to enable effective and scalable suicide prevention approaches at
justice intercepts (i.e., places behavioral health services can intercept a justice trajectory to change behavioral
health outcomes). This Core provides resources to support rigorous, reproducible research that shares similar
conceptual frameworks, methods, and measures. Center Methods are innovative in that they:
1. Establish a suicide prevention effectiveness evidence base for our large, high-risk target population.
2. Create an n~110,000 combined Center dataset that will be diverse and will be an asset to the field.
3. Develop, manualize, and refine strategies for scalability, sustainability, and large-scale translation, to
move the field forward for these important but understudied areas of implementation science.
4. Use contact with the justice system (e.g., police contact, arrest), as a novel indicator of suicide risk in the
general population (i.e., a “novel data type”) to identify at-risk individuals not well-connected with care
5. Demonstrate how health and justice system big data linkage is achieved and can be used to automate
and conduct suicide risk identification and response across health and justice systems at scale.
6. Leverage the Mental Health Research Network’s (MHRN’s) methods for extracting suicide-related and
healthcare utilization outcomes from claims and electronic health record (EHR) data.
7. Use sociometric identification of policy entrepreneurs to promote diffusion of Center approaches (Aim 4)
8. Partner with managed care organizations for suicide risk identification and prevention at justice intercepts
9. Convene health, justice, and suicide prevention communities, constituencies who do not often work
together, to create novel solutions to a common problem.
The Methods Core supports the Center through the following Specific Aims:
1. Engage Consortium Partners, promoting utility, uptake, scalability, & sustainability of Center findings
2. Incubate and generate innovative approaches to suicide prevention
3. Facilitate design and conduct of Center research projects, including transforming Center projects into
Hybrid effectiveness-implementation studies to promote scalability and sustainability of interventions
4. Disseminate Center methods and solutions and build national capacity for justice, health, and suicide
prevention cross-system research
5. Evaluate the Center’s processes, progress, productivity and impact
The Center is designed to shorten the translational pipeline through scalable solutions, hybrid trials, strong
stakeholder integration, and a strong dissemination plan. Strong integration of Methods Core Work Streams
and stakeholder perspectives will advance Center public health impact.